Aging, Inflammation, and Immunity

ABSTRACT Support is requested for a Keystone Symposia conference entitled Translational Systems Immunology organized by Drs. Sally John, Soumya Raychaudhuri, Michael Vincent and Mark M. Davis. The conference will be held January 28 - February 1, 2018 in Snowbird, Utah. Advances in large-scale data acquisition, immune phenotyping and computational biology are transforming immunology research and allowing unprecedented insights into the networks, pathways and systems that influence human health and disease. This meeting will cover the exciting technology advances that are enhancing our ability to elucidate human immune function and networks as well as practical applications in drug and biomarker discovery and patient stratification. The meeting begins with a look at progress in human genetics and the use of sequencing to assign functional mutations to rare human immune phenotypes. The impact of common variants on immune function requires larger sample sizes, and speakers will cover how genome-wide high-throughput genomics in combination with detailed phenotyping and physiologically relevant perturbations are providing foundational data sets that allow an unbiased view of immune function in cells and tissues. Also discussed will be emerging computational and analytical methods that enable integration and interpretation of high-content molecular data. The meeting will then move on to look at the application of these technological advances, expanding investigation to study the immune response in tissues and organs to enable a deeper understanding of interaction between immune and non-immune cells and their respective roles in disease states. Critical to clinical progress is the translation of systems immunology research into novel therapies and diagnostic or prognostic tests. Sessions themed around infectious disease and vaccine development advances in immune-oncology and patient stratification in complex disease and treatment response aim to provide depth from foundational science to clinical translation. Finally, a key goal is fostering collaboration across disciplines and the development of novel ideas. The meeting will be relevant for immunologists, computational biologists and clinicians with an interest in molecular characterization of the immune system.

Public health relevance
PROJECT NARRATIVE Advances in technology have helped to expand investigation to study the immune response in tissues and organs to enable a deeper understanding of interaction between immune and non-immune cells and their respective roles in disease states. Critical to clinical progress is the translation of systems immunology research into novel therapies and diagnostic or prognostic tests. This conference will focus themes around infectious disease and vaccine development advances in immune-oncology and patient stratification in complex disease and treatment response, aiming to provide wide ranging perspectives from foundational science to clinical translation.